Development and validation of a viral vector for targeted inhibition of DG granule cells

PROJECT SUMMARY/ABSTRACT
Epilepsy is one of the most common neurological disorders. Approximately one third of patients are drug-
resistant, underscoring the need for alternative therapies. One of the biggest challenges to developing disease-
modifying therapies is the limited understanding of the underlying mechanisms behind the initiation and
propagation of seizures. We propose to develop a novel, translational gene therapy that targets dentate gyrus
(DG) granule cells, which have been shown to act as a seizure gate. We will make use of a promoter specific to
DG granule cells, Prospero-related homeobox 1 (Prox-1), to selectively express the inhibitory DREADD,
hM4D(Gi), in these cells. We hypothesize that this novel gene therapy with high translational potential will
effectively suppress spontaneously recurring seizures in the intrahippocampal kainic acid (IHKA) mouse model
of temporal lobe epilepsy. We will first develop and test the sensitivity and specificity of a truncated Prox-1
promoter and enhancers (Aim1). We then will examine the efficacy of a Prox-1::hM4D(Gi)-YFP viral vector in
inhibiting DG granule cells and suppressing chronic seizures in the IHKA mouse model of epilepsy, while also
testing memory effects (Aim 2). Development of an effective and highly translatable therapy can help us better
understand the mechanisms at play during seizures, as well as improve treatment in patients with drug-resistant
epilepsy. In addition to its utility in epilepsy, a Prox1-driven expression vector could have potential applications
in Alzheimer’s disease and neuropsychiatric disorders as well as in lymphatic and cancer research.

Public health relevance
PROJECT NARRATIVE Approximately one third of patients with temporal lobe epilepsy do not respond to currently available antiseizure drugs, and many are not candidates for surgical resection. Inhibiting granule cells of the hippocampus effectively arrests seizures in a mouse model of temporal lobe epilepsy, but translation of this therapy is being hampered by the inability to specifically target these cells in non-genetically modified organisms. In this project we will develop a viral vector to specifically deliver a gene therapy to inhibit the hippocampal granule cells in wild type mice with the goal of developing a novel and translatable gene therapy to stop seizures in patients with drug- resistant temporal lobe epilepsy.